The Native American Research Internship (NARI) Summer Program in Child Health

Project Summary / Abstract
Compared to the general U.S. population, the American Indian/Alaska Native (AI/AN) populations are young
and growing. One-third of the AI/AN population is younger than 18 years. AI/AN young people face health
disparities which start in utero and continue into adulthood. AI/AN represent ~1% of the United States
population but only 0.3% of physicians and medical school faculty, and 0.05% of the science and engineering
workforce. While AI/AN have many educational disadvantages, the American Community Survey reports that
9.6% of the AI/AN population do achieve a bachelor's degree or higher. These are the students -
underrepresented and underserved in higher education and in bioscience career fields – with whom we work to
engage though our Native American Research Internship (NARI) program. NARI is a 10-week summer
research internship offered through the Department of Pediatrics at the University of Utah. NARI provides
hands-on basic or clinical research opportunities with established scientists, professional skills training, and
cultural mentoring from Native elders, faculty, and students. To date, 92 participants representing 38 tribal
nations, 32 colleges/universities, and 22 home states, have participated in the program. Of the 92 participants,
22 (24%) are currently undergraduates working towards a science degree, 19 students have been accepted
into graduate school (21%), 17 students have been accepted into medical school (18%), and 70 (76%) have
completed a bachelor's degree in science. Tribal elders, who have helped us create NARI, have told us that
child health is important to the AI/AN community. We propose to expand the existing NARI program to
include research experiences and educational training in child health and human development (NARI-
NICHD). By supporting AI/AN undergraduates interested in pursuing biomedical careers focused on child
health and human development with the proposed NARI-NICHD program, we will increase AI/AN
representation and leadership in the biomedical sciences and fulfill our ultimate goal of narrowing the gap of
health disparities among children in AI/AN communities.

Public health relevance
Project Narrative This proposal seeks to expand the successful holistic University of Utah Native American Research Internship (NARI) program to include summer research experiences in child health and human development (NARI- NICHD). The proposed NARI-NICHD program will pair researchers focused on child health at the University of Utah with American Indian/Alaska Native (AI/AN) undergraduates who aspire to help understand why certain health problems affect AI/ANs so disproportionately. The overarching goal of the NARI-NICHD program is to increase the diversity of the U.S. biomedical science workforce and reduce health disparities in the AI/AN population by supporting the scientific development of each undergraduate NARI-NICHD participant.